The role of platinum-regulated lipid metabolism in tau-related dementia

PROJECT SUMMARY
Alzheimer's disease (AD) is characterized by widely distributed neurofibrillary tangles (NFTs), which plays an
important role in AD pathogenesis. NFTs are composed of abnormal tau aggregates filling the neurons.
Pathologic tau can activate the proinflammatory signaling in microglia and induce neuroinflammation, which
forms a “vicious cycle” and significantly contributes to the disease progression and severity of AD. Moreover,
activated microglia can subsequently cause a pronounced transformation of astrocytes called "reactive
astrocytosis", leading to substantial neurotoxicity in AD. Increasing evidence demonstrate a critical role of
aberrant microglial lipid metabolism in AD. Microglia exhibit a “lacy” phenotype featuring highly enriched lipid
droplets, and lipid-laden microglia represent a dysfunctional and proinflammatory state. These observations all
point to an important functional link between aberrant lipid metabolism, microglial dysfunction, and
neuroinflammation. However, there are still significant knowledge gaps in understanding the complex network
including both genetic variants and non-genetic insults that induces lipid-mediated microglial dysfunction.
We previously uncovered that tumor-derived long-chain fatty acids critically contribute to lipid accumulation
and consequently dysfunction of tumor-infiltrating dendritic cells. Our preliminary data also discovered that
platinum agent (e.g. cisplatin and carboplatin), one of the most widely used chemotherapy agents for a variety
of cancers, further exacerbates lipid accumulation and dysfunction of dendritic cells through reprograming of lipid
metabolism in cancer cells. While studying how platinum treatment affects lipid metabolism in cancer cells as
well as surrounding immune cells, we unexpectedly discovered that platinum also induces aberrant lipid
accumulation in the brain, particularly in microglia. Importantly, this platinum-induced reprograming of lipid
metabolism is associated with tau pathology in vivo. Therefore, the recently discovered neuron-microglia “lipid
communication” may be impacted by platinum treatment, which may contribute to neuroinflammation, pathologic
tau spreading and AD disease progression. We hypothesize that, platinum treatment, through reprograming lipid
metabolism in neurons, promotes production of neuron-derived, fatty acids-enriched exosomes, which leads to
lipid accumulation in surrounding microglia. This platinum-induced lipid accumulation consequently induces
proinflammatory state of microglia and drives neuroinflammation, which further promotes pathological tau
spreading and severity of AD. We will test our hypothesis through the following aims: Aim 1: To investigate the
mechanism by which platinum drives microglial lipid accumulation. Aim 2: To elucidate how platinum-induced
neuron/microglial lipid reprogramming promotes neuroinflammation and AD progression.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) and tauopathies are characterized with widely distributed neurofibrillary tangles (NFTs) which is composed of abnormal tau aggregates and plays an important role in the pathogenesis of AD. Pathologic tau can activate the proinflammatory signaling in microglia and induce neuroinflammation, further promoting disease progression and severity of AD. This proposal seeks to uncover how a widely used anti-cancer chemotherapy agent, platinum, promotes dysregulation of lipid metabolism in microglia, neuroinflammation and tau pathology.